Deciphering the mechanics of microtubule networks in mitosis

Project Summary
Cells perform mechanical tasks across a wide range of processes including segregating chromosomes during
cell division. These tasks are accomplished by the organization of force-generating cytoskeletal networks.
Micron-scale microtubule networks need both motor and non-motor proteins to move and organize filaments into
proper functional mechanical units. Our long-term goal is to decipher the mechanical code that underlies the
assembly and function of these networks, using mitosis as a model biological process. To achieve this goal, we
will employ biochemical reconstitution, biophysical methods, single-molecule fluorescence microscopy, and live-
cell imaging. We will build on our recent publications and unpublished preliminary data to focus on microtubule
network mechanics in mitosis in the following three Aims: (1) Determine the mechanical and functional
differences between bridging fibers in metaphase and the central spindle microtubule network in anaphase.
Specifically, we will dissect the molecular mechanisms of an essential crosslinking non-motor MAP, PRC1, that
builds distinct motifs within the mitotic spindle. These features include bridging fibers that connect sister
kinetochore fibers in metaphase and the central spindle midzone array in anaphase. PRC1 is cell cycle regulated
by CDK/cyclin B, and therefore is a biochemically distinct molecule in metaphase and anaphase. We will
assemble and mechanically probe filament networks to understand how the spindle is able to differentially
generate forces and remodel itself while moving chromosomes in metaphase and anaphase. Imaging live cells
during mitosis that express mutant PRC1 constructs will validate our in vitro findings. (2) Determine the molecular
mechanisms for MAP clustering and the functional role of MAP clusters in regulating microtubule organization.
Specially, we will examine how intrinsically disordered subdomains within PRC1 contribute to MAP clustering.
Our published and preliminary data suggests that PRC1 clusters significantly impede filament sliding, and that
the C-terminal unstructured domain mediates this effect. We will employ our biophysical and cell biological tools
to determine the effect that reducing clustering has on microtubule organization. (3) Determine how complexes
of motor and non-motor MAPs collectively regulate microtubule organization. We will examine how the
Kif4A/PRC1 complex generates forces during microtubule sliding, and how a steady-state overlap arrangement
produces resistive forces that maintain spindle midzone integrity. Together, our findings should advance our
understanding of how micron-scale microtubule networks regulate chromosome motions in mitosis. We aim to
elucidate a ‘code’ that defines how the structure and biochemistry of different MAPs gives rise to cellular
machinery that can perform mechanical work. Errors in microtubule network assembly due to copy number
variations or mutations in essential MAPs are linked to disease in humans. Our research will shed light on the
biophysical properties that link network failure to disease states and may lead to therapies that target these
proteins or provide insights into diagnostic tools for assessing disease progression.

Public health relevance
Project Narrative Our cells need to accomplish mechanical tasks such as segregating chromosomes in a timely manner during cell division. Currently, we do not know how the extensive protein networks needed to accomplish these functions regulate their force production, as many different specialized proteins are involved, and we therefore do not understand the link between the breakdown of these networks in diseases such as cancer. My lab will fill this critical knowledge gap by (1) building essential cytoskeletal networks out of purified components (2) applying advanced biophysical and microscopy techniques to directly measure these tiny forces while also watching how the proteins respond under conditions relevant to both healthy and diseased cells.